FAMILY STUDIES OF ALCOHOLISM

The Unit of Family Studies has two major functions (1) to recruit and assess alcoholics, controls and their families, for various investigators within the Laboratory of Clinical Studies; and (2) to conduct psychosocial studies of alcoholic families and their individual members. In the current year, Unit staff have focused on coding and entering onto a computer the data collected since the inception of the Laboratory. A series of correlational studies comparing different subtypes of alcoholics are underway. A preliminary study comparing suicidal versus non-suicidal alcoholics on clinical, psychosocial and family variables has been carried out. In addition, the Unit has begun a study examining middle class black alcoholic families. Unit staff have also been collaborating with the Unit on Genetic Studies in identifying and phenotyping several pedigrees for linkage analysis.